Differences in Blood Pressure Phenotypes and Outcomes in Black and White Persons

The summary/abstract section is not required for Diversity Supplements per post documentation in the NHLBI
Research Supplement Application Guidelines posted on https://www.nhlbi.nih.gov/grants-and-training/training-
and-career-development/nhlbi-research-supplement-application-guidelines and FOA PA-21-071: “Research
Supplements to Promote Diversity in Health-Related Research (Admin Supp - Clinical Trial Not Allowed).”

Public health relevance
The narrative section is not required for Diversity Supplements per post documentation in the NHLBI Research Supplement Application Guidelines posted on https://www.nhlbi.nih.gov/grants-and-training/training-and-career- development/nhlbi-research-supplement-application-guidelines and FOA PA-21-071: “Research Supplements to Promote Diversity in Health-Related Research (Admin Supp - Clinical Trial Not Allowed).”